TUMOR SPECIFIC DELIVERY OF VERTICILLIN A OVERCOMES EPIGENETIC SILENCING RESPONSIBLE FOR DRUG RESISTANCE

ABSTRACT
This proposal describes an innovative solution to a primary cause of treatment failure in mesothelioma: drug
resistance. The solution is the controlled and targeted delivery of a novel epigenetic modifying agent –
verticillin A or one of its analogs – which re-establishes chemotherapeutic susceptibility in chemotherapeutic
resistant tumors via re-expression of epigenetically silenced tumor suppressor genes. Unlike other small
molecule epigenetic agents, including FDA-approved drugs, which are global DNA methylation and histone
deacetylase inhibitors, Verticillin A selectively targets H3K9me2/3. A stimuli-responsive particle drug delivery
system employing a unique materials-based targeting strategy is used in order to ensure that the verticillin and
chemotherapeutic agents localize and concentrate in peritoneal tumors. This pH-responsive drug delivery
system leverages fundamental pathophysiological properties of tumors (e.g., mildly acidic extracellular
environment and high metabolic rate) to induce compositional and architectural changes (e.g., particle swelling
from 0.1 to 1 micron) resulting in tumor-specific accumulation. This materials-based targeting approach
overcomes limitations of traditional strategies (e.g., passive targeting via the enhanced permeability and
retention effect, and active targeting via antibody-based affinity) while providing a platform to deliver both
hydrophobic and hydrophilic drugs via single- and double-emulsions, respectively. The proposed
experiments will test the hypothesis that delivery of a verticillin agent with a chemotherapeutic
(combination therapy either as single agents or co-formulation with encapsulated or free drug) to
mesothelioma tumors will overcome drug resistance and extend survival compared to the delivery of
verticillin or the chemotherapeutic alone. Importantly, key preliminary data are in support of the proposed
studies, well-characterized materials and rigorous experimental designs are established, and essential cross-
disciplinary collaborations and expertise are in place to address this hypothesis. The specific aims of this five-
year proposal are: Aim 1. Evaluate the epigenetic activity of verticillin A and five of its analogs in human
mesothelioma cells (MSTO-211H) and tumor cells collected from patient pleural effusions as well as the
toxicity profile via in vitro assays for hepatotoxicity, cardiotoxicity, and mitochondrial toxicity. Aim 2. Optimize
the co-formulation of the two verticillin agents with paclitaxel, cisplatin, or pemetrexed to achieve the maximum
cytotoxic effect in drug resistant mesothelioma cell lines and tumor cells collected from patient pleural
effusions. Aim 3. Assess toxicity in healthy mice and PK and PD / efficacy of the optimized formulation in
patient-derived xenograft (PDX) murine models of drug resistant mesothelioma.

Public health relevance
Narrative The systematic development of a combination therapy is described for the treatment of mesothelioma consisting of a novel small molecule epigenetic modifying agent from the verticillin A family (epipolythiodioxopiperizine alkaloids) and a chemotherapeutic agent delivered using a unique drug delivery system that localizes and concentrates the agents to peritoneal tumors. Re-expression of epigenetically silenced tumor suppressor genes (i.e., alteration of the epigenetic profile) to overcome drug resistance is a key strategy for improving cancer patient care. Specifically, this class of epigenetic agents restores the activity of well-established and commonly used chemotherapeutics through selective histone methyltransferase inhibition rendering it a compelling agent in combination therapies.